IGF::OT::IGF BASE AWARD; STANDARDIZED RECHARGEABLE ELECTRONIC NICOTINE DELIVERY SYSTEM; POP MARCH 16, 2015 THROUGH NOVEMBER 30, 2015. N43DA-15-8921. EXTEND THE PERIOD OF PERFORMANCE FOR NO ADDITIONAL

Under this Small Business Innovation Research (SBIR) Phase I, Research Topic 156, for Standardized RechargeableElectronic Nicotine Delivery System, the contractor will develop a standardized Electronic Nicotine Delivery System(ENDS), which can be sold to investigators to enable the proper conduct of clincal trials involving ENDS.